Deep rTMS modulating insula synaptic density and smoking behavior in schizophrenia

PROJECT SUMMARY
Patients with schizophrenia (SCZ) have a higher prevalence of smoking than the general population and respond
poorly to conventional treatments. This is of great concern, as cigarette smoking contributes to earlier mortality
in SCZ and it can exacerbate ongoing psychotic symptoms. In 2020, deep repetitive transcranial magnetic
stimulation (dTMS) of insular and prefrontal cortices at high frequency, using the H4 coil – also termed the HADD
coil – was given FDA clearance for smoking cessation in tobacco use disorder (TUD), based on results from a
large, multisite clinical trial. Our preliminary data indicate that this emerging neurostimulation approach may also
hold promise for smoking disruption among patients with SCZ. However, there is a critical need for a better
understanding of the underlying neurobiological mechanisms of the treatment. There is also a more fundamental
scientific question pertaining to whether TMS in fact rewires the underlying brain mechanisms that it purports to
target with the stimulation; the ability of TMS to change brain circuity in vivo has been widely assumed, but the
mechanism of action remains an open question. The overall aims of this R61/R33 application are to test whether
dTMS is capable of inducing plasticity (i.e., changing synaptic density) and modifying functional circuits of its
putative (insula) target in patients, and to test whether these cellular and neural changes drive a potential
therapeutic signal for smoking disruption in SCZ. The R61 phase will be a proof-of-concept in 16 patients, testing
if 15 sessions of dTMS over 3 weeks (versus sham) to the insula and prefrontal cortex: (1) modifies insula
synaptic density, measured with positron emission tomography (PET) and [11C]UCB-J, a well-validated
radiotracer that binds to a synaptic vesicle protein, SV2A; and (2) disrupts smoking behavior, measured as the
choice to self-administer tobacco in a laboratory model of tobacco choice. If during the R61 phase we observe
a change to insula synaptic density and tobacco self-administration with clinically-meaningful effect sizes
(benchmarks defined a priori), we will proceed to the R33 phase of the study. During the R33 phase, we will
study 22 additional smokers with SCZ (totaling 38 patients over the entire R61/R33 study). Our first goal during
the R33 phase of the study will be to confirm statistical reliability of the dTMS effects on synaptic density and
self-administration. Our additional goals during the R33 phase will be test the effects of dTMS on insula network
connectivity, using resting-state fMRI; and to test whether dTMS-induced changes to the respective PET and
fMRI measurements correlate with dTMS-induced changes to tobacco self-administration following treatment.
Results of this study have the potential to inform future clinical trials of dTMS for smoking cessation in SCZ, and
to increase basic knowledge into the neural mechanisms of therapeutic neurostimulation.

Public health relevance
PROJECT NARRATIVE If this mechanistic multimodal brain imaging study succeeds, it will lay the groundwork for developing future smoking cessation trials using deep repetitive transcranial stimulation (dTMS) in patients with schizophrenia. Furthermore, as the mechanism of action of TMS is not well-understood, our study will also help address a fundamental neuroscientific question about whether TMS is capable of inducing synaptic plasticity in humans.